University of Colorado Anschutz Medical Campus DRC

CENTER OVERVIEW
PROJECT SUMMARY/ABSTRACT
The University of Colorado Anschutz Medical Campus (CU-AMC) is world renowned for basic, translational, and
clinical diabetes research and treatment of both Type 1 and Type 2 diabetes (T1D and T2D), and their related
complications. During its first funding cycle, the CU-AMC DRC has already strengthened and enhanced diabetes
research in Colorado by providing: 1) state-of-the-art research technologies and specialized resources to
maximize effective and innovative research; 2) access to patient samples and data; 3) enrichment programs,
education and seminar series to the diabetes community; and 4) by attracting new scientists into the diabetes
field through the Pilot and Feasibility program and active recruitment activities. These objectives have been
realized by providing new and improved infrastructure and access to specialized reagents and resources that
are critical for diabetes-related research, and an environment that promotes scientific interactions, research
discoveries, and progress towards diabetes treatment and cures. The CU-AMC DRC is primarily located on the
Anschutz Medical Campus (AMC) in Aurora, Colorado where the majority of CU-AMC DRC clinical and research
departments are located. Now that the DRC is established, we have also welcomed members from the University
of Colorado Denver and Boulder campuses, Colorado State University and the School of Mines to diversify our
research base. Our broad diabetes research base currently includes 103 basic, translational, and clinical
scientific investigators across three AMC schools (Medicine, Nursing and Pharmaceutical Sciences) and
includes 27 departments/divisions. The membership currently brings diabetes/diabetes-related direct
cost grant support totaling > $65 million in individual grants and >$10 million in center and training
grants. Drs. Lori Sussel, PhD. and Jane Reusch, MD bring together complementary areas of scientific
backgrounds and expertise to oversee the organization and scientific focus of the CU-AMC DRC. Despite the
challenges brought on by the COVID-19 pandemic, we have successfully established four Biomedical
Research Cores to provide cutting-edge technologies in Clinical Resources, Tissue Procurement and
Processing, Diabetes Modeling and Cell and Tissue Analysis. The CU-AMC DRC Pilot and Feasibility
Program has also successfully recruited promising young faculty into diabetes-related research and encouraged
established investigators from other fields to enter the diabetes field. The Dean of the CU-AMC DRC School of
Medicine has assisted with recruitment packages for bringing new diabetes expertise to campus, supported the
purchase of equipment for our DRC core facilities and pledged to supplement the P&F budget by $150,000
annually. Finally, the CU-AMC DRC Enrichment Program has promoted the interaction between diabetes
researchers at CU-AMC by providing seminar forums for exchange of research findings, providing opportunities
to form collaborative relationships, and encouraging cross-pollination between the diverse diabetes
communities.

Public health relevance
CENTER OVERVIEW PROJECT NARRATIVE The University of Colorado Anschutz Medical Center (CU-AMC) is renowned for its basic, translational and clinical diabetes research programs, which encompass Type 1 and Type 2 diabetes, diabetes complications and autoimmunity. The purpose of the CU-AMC Diabetes Research Center (DRC) is to unite this community and facilitate their research endeavors by providing efficient and innovative shared resources, developing enrichment programs to facilitate interactions and collaborations between center members, and implementing a strong pilot and feasibility program to bring new investigators into the diabetes field. These efforts will result in improved understanding of disease etiologies and progression, and promote the development of diabetes treatments and cures.